Flow Cytometry (FLOW)

PROJECT SUMMARY/ABSTRACT (FLOW CYTOMETRY SHARED RESOURCE)
The Flow Cytometry Shared Resource (FLOW-SR) was established in 1984 and has been continuously funded
by the University of Michigan (U-M) Rogel Cancer Center (Rogel) since 1988. The SR received a merit rating of
“Outstanding” at the time of last renewal. While FLOW-SR is available to all U-M faculty, it has been heavily
utilized by Rogel members throughout its history. It is well recognized that flow cytometric analysis and cell
sorting are critical for measuring a variety of cellular biomarkers and processes in cancer-related life science
disciplines including cell biology, immunology, biochemistry, genetics, and pharmacology. Thus, FLOW-SR is
highly relevant to Rogel Research Programs.